Novel strategy to enrich brain DHA through diet: Potential application for the prevention of Alzheimer's disease

Alzheimer’s disease (AD) is the leading cause of dementia, and affects about 5 million
Americans at present. It is projected to afflict 16 million Americans by 2050 and cost the
economy $1.1 trillion. The prevalence of AD is much greater in veterans than in the general
population because of a constellation of risk factors including age, traumatic brain injury,
depression, and PTSD all of which are more prevalent in the veterans. While there is no
effective treatment for AD at present, several studies in animal models have shown beneficial
effects of docosahexaenoic acid (DHA) which is uniquely concentrated in the brain, and is
known to be essential for its function. However, clinical trials using the currently available DHA
supplements (fish oil, krill oil, algal oil, ethyl esters etc) to improve cognitive function in patients
have been disappointing. We postulate that this failure is due to the inability of these
supplements to enrich brain DHA at the recommended safe doses, because they are all
absorbed in the form of triacylglycerol (TAG) rather than in the phospholipid form required by
the transporter at the blood brain barrier (BBB). We have recently demonstrated that dietary
DHA in the form of lysophosphatidylcholine (LPC), which is absorbed in the phospholipid form,
not only enriches brain DHA at low doses, but also improves cognition and spatial memory in
normal mice. The current proposal will explore the potential of LPC and other lysophospholipids
(LPL) in enriching brain DHA and in the prevention of AD in a mouse model of the disease.
In Aim 1, we will test the hypothesis that dietary DHA-lysophospholipids (LPL) are superior to
either TAG-DHA (as in fish oil) or natural phospholipid DHA (as in krill oil) in enriching the brain
DHA and improving cognitive function in normal mice. In addition, the effect of the polar head
group of the LPL (choline, ethanolamine, or serine), as well as the effect of eicosapentaenoic
acid (EPA) will be determined, to identify the most efficient LPL for improving the brain function.
In Aim 2, we will test the hypothesis that treatment with a low dose of LPL-DHA (identified in
Aim 1) will prevent or delay the development of AD in a double transgenic mouse model of AD.
Three-month-old APPswe/PS1ΔE9 mice will be treated with either LPL-DHA or TAG-DHA at a
daily dose of 40 mg DHA/kg for 9 months, and the effects on cognitive behavior, memory, and
neuropathology will be determined. It is anticipated that LPL-DHA, but not TAG-DHA would
alleviate the pathological symptoms of AD at these low doses.
In Aim 3, we will determine the mechanisms underlying the beneficial effects of LPL-DHA,
compared to the currently available supplements of DHA, in enriching brain DHA and in
improving brain function. The hypotheses to be tested include: a) that the metabolic advantage
of LPL-DHA is due its ability to cross both the intestinal barrier and blood brain barrier, b) that
LPL-DHA is more anti-inflammatory than free DHA, c) that LPL-DHA is oxidized less rapidly in
the brain than free DHA, and d) LPC-DHA contributes choline, the essential component of
acetylcholine, in addition to DHA, which has pluripotent effects on brain function and AD
development.
Successful completion of these studies could lead to a novel nutraceutical strategy for the
prevention and treatment of AD, as well as other neuro-inflammatory diseases in the population
in general, and in the veterans in particular.

Public health relevance
The prevalence of Alzheimer’s disease (AD) is much greater in the veterans than in general population, but there is no effective treatment for it. Because of the well-known beneficial effects of docosahexaenoic acid (DHA), an omega 3 fatty acid, for the brain, it has been used with some success in the animal models of AD. However, clinical trials with the currently available DHA supplements (fish oil, krill oil, ethyl esters) have been unsuccessful in improving cognitive function in patients, apparently because of the inability of these supplements to increase brain DHA levels at the safe doses recommended by FDA. This proposal aims to develop a novel approach, employing a tailored phospholipid form of DHA, which specifically enriches brain DHA and improves memory at low doses. The potential of this compound in the prevention or mitigation of AD, and the underlying mechanisms of its action will be investigated, employing a mouse model of AD.